AGR2-superantigen vaccine conjugate for the treatment of pancreaticductal adenocarcinoma

Project Summary/Abstract
Pancreatic ductal adenocarcinoma (PDAC) is one of the deadliest forms of cancer. Poor survival rates are largely
due to the late stage at which PDAC is diagnosed and a lack of effective targeted therapies. While the field of
immunotherapy has significantly increased overall survival in some malignancies, they have not translated to
PDAC. The long-term goal of this research program is to develop a novel cancer vaccine for the treatment of
PDAC. Preliminary studies by our group and others have shown that the Anterior Gradient-2 (AGR2) protein, a
member of the protein disulfide isomerase (PDI) family, is induced during PDAC oncogenesis and highly
expressed in >90% of PDAC patients. AGR2 has intracellular oxidative folding function and is also released from
the cell where it localizes to the surface of PDAC cells and is shed into the tumor microenvironment. We
hypothesize that AGR2 is an actionable target for the development of a PDAC targeted vaccine and will test that
theory using a new immunotherapy drug candidate. Streptococcal Mitogenic Exotoxin Z-2 (SMEZ-2) from
Streptococcus pyogenes is a bacterial superantigen (SAg) that binds to MHC II molecules on antigen presenting
cells (APCs) with high affinity. In preliminary studies we generated a detoxified AGR2-SMEZ-2 conjugate that
we hypothesize will stimulate a robust anti-PDAC immune response. We found in preliminary studies that AGR2-
SMEZ-2 generates a robust anti-AGR2 response in mice and displays no overt toxicity. The objectives of Phase
1 of this study are: (1) to demonstrate anti-PDAC efficacy of AGR2-SMEZ-2 in vivo, and (2) to measure B and T
cell biomarkers of an anti-AGR2 response in vaccinated mice. Upon success in Phase 1, the objectives of Phase
2 of this study are: (1) to show synergy between AGR2-SMEZ-2 vaccination and checkpoint inhibition in vivo,
(2) to compare the superior immunogenicity of SMEZ-2 mediated through MHC II-specific binding over existing
vaccine carrier proteins, and (3) to determine the optimal dose, schedule, and toxicology profile of AGR2-SMEZ-2 in vivo. This work is innovative because we will investigate the anti-PDAC mechanism of our proprietary AGR2-
SMEZ-2 vaccine and characterize the induced immune response in different mouse models. This work will
support the development of a first-in-class vaccine for the treatment of PDAC, a cancer with few existing
therapies. In addition, we expect that this study will allow for other immunotherapies (namely checkpoint
inhibition) to become effective in providing a PDAC response in patients.

Public health relevance
Narrative (Relevance) Pancreatic cancer is one of the deadliest cancers and effective therapies are lacking. We have developed a vaccine-based immunotherapy approach to target the Anterior Gradient-2 (AGR2) protein, which is highly expressed in pancreatic tumors. Our strategy relies on utilizing AGR2 conjugated to the bacterial superantigen (SAg) SMEZ-2 that activates a robust anti-AGR2 immune response. We anticipate that these studies will reveal new ways of treating pancreatic cancer in preclinical models of cancer, setting the stage for clinical development and the delivery of a new treatment regimen to patients in need.